IND-enabling development of Radioprotectin 1: a dual GI/HE radiation mitigator

The US population at large, and particularly military personnel and first responders, are at risk of radiation expo-sure due to the explosion of a nuclear device, a nuclear reactor accident, and the threat of radiation terrorism.
There is no radiation medical countermeasure (RCM) drug approved by the FDA that meets the criterion of a
gastrointestinal (GI) radiomitigator – an agent which mitigates the acute GI radiation syndrome (GI-ARS) when
administered after the exposure. Ionizing radiation kills cells that are unable to repair their DNA, primarily via
mitotic catastrophe and apoptotic cell death. Post-irradiation genotoxic stress and cell injury is an unsolved
medical problem. A critical barrier to progress in development of RCM drugs is that a traditional human
clinical trial is not an option. Therefore, FDA approval of a RCM is done under the Animal Rule that requires
detailed understanding of its mechanism of action, demonstration of its safety, and efficacy in animal models,
and its safety in humans. In this transitional research proposal, we propose studies to fully satisfy the mech-anism of action requirement of the Animal rule for Radioprotectin-1 (RP-1) a new radiation mitigator we devel-oped with previous NIAID funding and develop a single-dose extended release formulation that meets CONPOS
requirements of a RCM. Our overall goal is to prepare RP-1 for regulatory approval as a first-in-class synthetic
GI radiation mitigator. RP-1 is the first specific agonist of the lysophosphatidic acid (LPA) receptor subtype 2
(LPA2) with picomolar EC50, which reduces radiation injury-induced mortality in mice. Our central hypothesis
is that RP-1–activated, uniquely long-lasting (> 16h) signaling mediated by the LPA2 G protein-coupled receptor
(GPCR), is responsible for mitigation of genotoxic stress and promotion of cell survival. Our hypothesis predicts
that RP-1 achieves this via 1) obligate stimulation of the LPA2 GPCR, 2) sequential recruitment of supramolecular
signaling interactomes responsible for the long duration of its action, 3) augmentation of DNA repair and 4)
enhanced survival of LGR5 intestinal stem cells (ISC). Our objectives are: 1) determine in detail the unique
molecular mechanism of how RP-1 acts via LPA2 to recruit the interactomes required for overcoming genotoxic
stress, and 2) identify the specific subpopulation of ISC that is protected by RP-1 in vivo using transgenic mice
that express fluorescent protein in the LGR5 marker bearing ISC and 3) develop a single dose extended release
nanoparticle formulation that mitigates the GI-ARS. Although this information is necessary to move RP-1 forward
toward regulatory approval, the body of knowledge we will generate also represents significant and previously
unknown information concerning radioprotective signaling mechanisms.Our expected outcomes will include 1)
establishing that LPA2-dependent recruitment of the IEX-1–TRIP6–ERK1/2-AKT interactome is required for mit-igation of genotoxic stress; 2) defining the role of RP-1 effects that enhance DNA-dependent Protein Kinase-dependent DNA repair and prosurvival signals; 3) demonstrating that RP-1 is an effective mitigator of GI-ARS
by protecting ISC in mice; 4) a single-dose extended-release RP-1 formulation. The impact of our project will
directly affect our first-response options in treating patients with radiation injury. The aims of the project are:
Aim 1. Test the hypothesis that RP-1 via LPA2 mediates long-lasting activation of DNA repair and pro-survival signaling in LGR-5 positive intestinal stem cells.
Aim 2. Develop a nanoparticle-based extended-release RP-1 formulation for the treatment of the GI-ARS
of mice and Rhesus macaques.
All data obtained will be used for a RP-1 Drug Master file and presented to the FDA during our PRE-IND meeting
in the final year of the project and shared with the research community at large.